S-nitrosylation signaling in asthma

PROJECT SUMMARY/ABSTRACT
Project 1
Asthma afflicts over 7% of Americans and is the result of chronic inflammation of the airways leading to airway
remodeling and hyperresponsiveness that impedes air flow. Severe asthma is asthma that remains problematic
despite maximal intervention with conventional asthma therapies, and it accounts for the majority of the mortality
and cost of asthma. Dysfunction of airway β2-adrenergic receptor (β2AR) signaling contributes to severe asthma
pathogenesis, but the precise signaling mechanisms responsible are unclear. While activation of β2AR using
inhaled “β-agonist” drugs is a mainstay of acute asthma treatment, overactivation of β2AR is detrimental and can
be fatal. Airway β2ARs signal both through heterotrimeric G proteins and through G protein-coupled receptor
kinase (GRK)/β-arrestin pathways that also mediate receptor phosphorylation, desensitization, and
internalization. Through a long-standing collaboration, the Stamler and Gaston groups have found that airways
are regulated by nitric oxide (NO) through S-nitrosylation of thiols to form S-nitrosothiol (SNO), including on
cysteine residues in proteins, a post-translational modification that alters protein functions. In addition, SNO
forms on low molecular weight thiols, including glutathione to form SNO-glutathione (GSNO). We demonstrated
that inhaled GSNO elevates lung protein-SNO and is protective in asthma, identified the enzyme SNO-
glutathione reductase (GSNOR) that inactivates GSNO, and demonstrated that mice lacking GSNOR are
protected from developing asthma. Since the β2AR can activate NO synthase in the airways to generate NO,
there is a need to discover how this promotes endogenous SNO-mediated bronchoprotection. Our recent work
has shown that β2AR is S-nitrosylated after activation, and preventing SNO-β2AR with a point mutation augments
β2AR signaling. Importantly, mice bearing β2AR with a knock-in of this mutation are protected from developing
asthma. We have previously shown that β2AR regulators GRK2 and β-arrestin2 are S-nitrosylated to inhibit their
activity to desensitize the β2AR, and mice bearing GRK2-C340S and β-arrestin2-C253S knock-in exhibit heighted
β2AR activity and worsened injury in cardiac models. We have begun to test the efficacy of inhaled GSNO to
affect bronchorelaxation and improved lung function in patients, and these data and clinical samples uniquely
position us to examine the role of S-nitrosylation in regulating the β2AR pathway from bench to bedside. The
Central Hypothesis of Project 1 is that the β2AR signaling system is a key target and mediator of SNO-GSNO-
GSNOR protective effects in the airways in severe asthma. Our studies will define the role of S-nitrosylation of
specific β2AR signaling pathway components in a murine model of asthma, delineate the roles of inhaled GSNO
and of GSNO dinitrosylases on β2AR signaling components in murine models of asthma and in human lung
primary cells, and demonstrate that inhaled GSNO improves both airway flow and β2-agonist responsiveness in
severe asthma. This work complements the clinical aims in Projects 2 and 3 by providing a mechanistic link
between NO/GSNO/GSNOR actions and the regulation of β2AR signaling in severe asthma.